Advancing Machine Learning for CEST MRI Analysis through Partially Synthetic Data

PROJECT SUMMARY
Glioma represents a significant health concern, characterized by alterations in multiple macromolecules and
metabolites within the tumor microenvironment. Non-invasive imaging of these molecular profiles could provide
invaluable diagnostic insights. Chemical exchange saturation transfer (CEST) is an emerging molecular
imaging technique that offers enhanced sensitivity and provides complementary information to magnetic
resonance spectroscopy (MRS), with the ability to reflect various molecular compositions within tissues. Amide
proton transfer (APT), a primary variant of CEST that reflects mobile proteins, has demonstrated substantial
potential for glioma diagnosis. However, despite FDA approval for APT imaging in glioma in 2018, it has not
yet been integrated into clinical practice. A clinical trial aimed at differentiating gliomas using APT imaging was
halted due to poor image quality, likely resulting from the inaccuracy of existing CEST quantification methods
and the inherently low signal-to-noise ratio (SNR) of CEST imaging. Machine learning (ML) has the potential to
identify complex features that traditional methods often miss. While ML has been applied to quantify CEST, it
faces challenges such as insufficient training data and poor-quality ground truth data when trained using
measured in vivo data. Fully synthetic data can mitigate these issues, but practical application remains
challenging due to unidentified exchangeable pools and their parameter ranges in tissues. Our project aims to
develop a novel platform to generate partially synthetic CEST data for training ML models, thereby addressing
these challenges. Preliminary data suggest success in accurately quantifying APT in animal models in
preclinical MRI using an ideal steady-state continuous-wave saturation. In Aim 1, we will translate this
approach to human imaging at 3T by extending it to the more complex non-steady-state pulsed-CEST imaging
typically used in clinical MRI. We will also expand it beyond APT to include amine (glutamate), guanidine
(creatine), and nuclear Overhauser enhancement (NOE) effects (large proteins, phospholipids), enabling more
generalized CEST imaging of molecular profiles. In Aim 2, we will develop a novel autoencoder-based
denoising technique, coupled with an innovative dual-power data preparation strategy, to improve SNR. This
strategy leverages the high SNR of higher saturation power and the enhanced peak resolvability of lower
power, ensuring effective noise suppression while preserving molecular information. This will make the
technique more suitable for low-power applications, which are preferred for imaging multiple CEST effects at
3T. In Aim 3, we will integrate these two ML-based techniques and evaluate their performance in glioma
patients. By the completion of this project, we aim to overcome current challenges in CEST imaging, facilitating
its widespread clinical adoption and significantly enhancing healthcare outcomes.

Public health relevance
PROJECT NARRATIVE Although the amide proton transfer (APT) MR imaging has been approved by the FDA, it has not been widely adopted due to challenges related to the quantification accuracy and low SNR. The proposed machine learning-based methods to address these challenges align with the mission of the National Institute of Biomedical Imaging and Bioengineering (NIBIB) to improve health by leading the development of advanced imaging technologies.